Admin Core

Project Summary: ADMIN Core
The Administrative Core will serve all four Component Projects including Core B over the five
years of the Program Project. The overall goals of the Administrative Core are to serve as an
integrated unit for the entire Program Project team to monitor and foster coordination of the
scientific interactions across all Projects, maximizing collaborative interactions with each other,
with the subcontract investigators as well as the Internal and External Advisory boards. This Core
will be responsible for careful financial management of the Program Project, strict adherence to
all NYBC and NIH guidelines and research regulations, handle new hiring associated with staffing
the projects and schedule regular meetings of the entire Program Project. Aim 1 will provide
supervision of program finances, administrative and secretarial support, maintenance of
authorizations and adherence to institutional requirements, as well as coordination of the
subcontract to Montefiore Medical Center. Aim 2 will coordinate meetings of the Program Project
team, including the Project Leaders, Core Leaders, all scientific and technical staff at NYBC, and
all the members of the subcontract teams with the goal to facilitate sharing of systems, reagents
and findings among all groups within the Program Project. Finally Aim 3 will coordinate meetings
of the Internal and External Advisory Boards for the Program Project to ensure periodic review of
the projects/cores, next steps and future directions with the overall advisors.